Circuit architecture and dynamics of the insular cortex underlying motivational behaviors

PROJECT SUMMARY
The insular cortex (IC) is a multimodal hub that integrates interoceptive and exteroceptive information
to control diverse aspects of animal behaviors related to cognition, emotion, and motivation. Among
other functions, the IC receives information regarding an animal’s metabolic states and drives
motivation and valence-specific behaviors. However, our understanding of the neuronal substrates
and circuit principles underlying IC function is still in its infancy. An important step forward is to
determine the activities of individual neurons within discrete IC circuits before, during, and after an
animal behavior. To achieve this goal, a prerequisite is to delineate the events in individual IC
neuronal types that give rise to the diverse functions in motivated behaviors. However, two major
challenges exist. First, neuronal circuits are organized around subregions and neuronal types. It is
increasingly clear that traditional classifications of IC subregions and cell types are insufficient to
explain the functional diversity of the IC. Precise classification of subregions, neuronal types, and
neuron-specific connectivity is needed. Second, an animal’s internal state is in part encoded by
neuromodulators, such as dopamine, which dynamically modulate the functions of individual IC
circuits. Despite recent progress in measuring extracellular dopamine and other neuromodulators,
they trigger intracellular signaling events in a cell type-specific manner. Herein, we propose to
overcome these barriers by integrating the latest complementary technological advances from the
three PIs. First, we will use machine learning-based algorithms to comprehensively identify functional
subdivisions, neuronal types, and cell-specific connectivity in the IC. Second, we will link the activities
of individual IC cell types and subregions to animal vigor or valence using two-photon calcium imaging
through a gradient-index (GRIN) lens. Third, we will simultaneously image the dynamics of
cAMP/protein kinase A (PKA), a key intracellular signaling pathway mediating neuromodulation. Using
these approaches, we aim to gain an unparalleled understanding of the activities and
neuromodulations of discrete IC circuits that underlie vigor and valence processing, two essential and
distinct aspects of motivated behaviors, at cellular resolution. We will test the hypothesis that different
IC pyramidal neuronal types form distinct local and long-range circuits, which differentially yet
cooperatively drive vigor and valence for motivated behaviors in a manner depending on
neuromodulation.

Public health relevance
PROJECT NARRATIVE The insular cortex plays an essential role in diverse motivated behaviors involving the integration of interoception with exteroception, and dysfunction of the insular cortex is associated with addiction and mood disorders. We aim to integrate cutting-edge technological advances spanning multiple disciplines to visualize the precise activities and signaling events within defined neuronal circuits of the insular cortex that are involved in specific aspects of motivational behaviors. We expect that our study will reveal the logic of circuitry mechanisms underlying insular cortical function, which will in turn lead to an increased understanding of neuropsychiatric diseases associated with insular cortical dysfunction.